Frontiers in Reproduction (FIR) Training Course

Project Summary: This R25 application seeks five years of sponsorship for our advanced training course
entitled: Frontiers in Reproduction (FIR), held annually at the MBL in Woods Hole under the Directorship of Dr.
Rafael A. Fissore (UMass, Amherst). The course is directed towards advanced graduate students, post-doctoral
fellows, and physician-scientists who are committed to fundamental, translational or clinical research studies in
the field of reproductive biology. FIR introduces participating trainees to state-of-the-art research in the field,
spanning reproductive endocrinology, germ cell and organ development, gametogenesis and implantation and
placentation, and Assisted Reproductive Technologies (ART). We provide trainees with fundamental concepts,
knowledge of “cutting edge” research and laboratory techniques, career mentoring and instruction in the ethical,
legal, and societal impact of research in reproduction. To achieve this goal, we propose the following specific
aims: 1) Provide a coherent series of lectures covering fundamental concepts spanning the broad field of
reproductive biology and introducing students to the open questions in the field. 2) Provide lectures and
discussions on the emerging concepts and techniques in ART and its applications. 3) Train students in advanced
cellular and molecular techniques required to probe the cellular and organ function underlying reproduction
through state-of-the-art and hands-on demonstrations and mini-projects. 4) Provide opportunities for career
planning and advancement by offering training on scientific communication, data analysis, and oral
presentations. 5) Educate trainees on the ethical considerations involved in the use of human and animals, and
on the use of animals as research models. 6) Foster a diverse, collegial environment that leads to long-term
mentorship relationships and collaborations among trainees and between students and faculty. FIR is divided
into three topical scientific sections, each lasting 2 weeks. The course meets 5-6 days a week with 2 daily lectures
and hands-on laboratory exercises. FIR continually incorporates new faculty, topics and technological
breakthroughs to ensure that the training remains at the forefront of the field. The course will provide a significant
benefit to biomedical research through the training of new investigators in the field of reproductive biology and
biotechnology, and ART. Reproductive science is a broad and well-established field with enormous impact in
society and with biomedical implications across the entire spectrum of NIH’s portfolios.

Public health relevance
Project Narrative Continuous education and training of scientists in reproductive biology research is necessary to ensure discoveries that will fuel reproductive success and health in humans and animals. The development of new therapeutics and strategies, and the training of the next generation of scientists who will lead these advances, are essential to ensure our fertility and that of those species with whom we share the planet. The Frontiers in Reproduction Course at the Marine Biological Laboratory in Woods Hole, MA promotes discoveries in the field by bringing together scientific experts and students in an advanced, hands-on training course that teaches fundamentals and emerging concepts in reproductive biology, describes applications in the clinic, examines ethical issues and builds a strong community of highly skilled reproductive biology scientists.